Connecting 3D genome misfolding to transcriptional silencing in fragile X syndrome

Fragile X syndrome (FXS) is an inherited neurodevelopmental disorder associated with social anxiety,
hypersensitivity to stimuli, seizures, and learning disabilities. It is classically viewed as a monogenic disease in
which mutation-length expansion of a CGG short tandem repeat (STR) tract above a critical mutation-length
threshold of 200 triplets leads to local DNA methylation and repression of FMR1. Genome-wide gene expression
changes are thought to occur downstream of the loss of the Fragile X Messenger Ribonucleoprotein (FMRP)
encoded by FMR1. In our lab’s new data acquired during the previous funding period, we used nanopore long-
read sequencing, Hi-C, CUT&RUN, CRISPR STR engineering, and single-cell Oligopaint imaging to find
Megabase (Mb)-sized H3K9me3 domains on autosomes and the X-chromosome in FXS patient-derived cell
lines and brain tissue. Domains co-localize with severe misfolding of topologically associating domains (TADs)
and loops and connect via trans interactions in subnuclear hubs. Because H3K9me3 domains encompass STRs
susceptible to instability and replication stress-induced double strand breaks, we termed them BREACHes:
Beacons of Repeat Expansion Anchored by Contacting Heterochromatin. BREACHes encompass and silence
genes encoding synaptic plasticity, epithelial integrity, reproductive development, and neural cell adhesion,
which are clinical hallmarks in FXS. Thus, by way of Mb-scale heterochromatin domains and trans interactions,
we find multiple plausible candidate genes of possible relevance for understanding onset, progression or
therapeutic treatment of FXS. The objective of this proposal is to elucidate the RNA-mediated and higher-order
folding mechanisms governing heterochromatin domains and the trans interactions among them in FXS. Our
central hypothesis is that mutation-length CGG STR-containing RNA forms RNA:DNA hybrid structures to
establish H3K9me3 domains, whereas the attenuation of cohesin-mediated loop extrusion is necessary to
maintain H3K9me3 and trans interactions. We will test our hypothesis with two Specific Aims. First, we will
investigate the role for CGG STR-containing RNA in BREACH establishment. To model the removal of H3K9me3
signal and the subsequent re-establishment of the domains, we will reprogram normal-length, FXS mutation-
length, and premutation-length cutback induced pluripotent stem cells (iPSCs) from primed to naïve pluripotency
and release back to primed. In a timecourse of BREACH re-establishment, we will assay R loops, RNA-chromatin
interactions, histone methyl transferases, and 3D genome folding. Second, we will elucidate the effect of cohesin-
mediated loop extrusion on BREACH maintenance in single cells. We will deplete and replete the cohesin
unloading factor WAPL in FXS iPSCs. In a timecourse of recovery and loss of cohesin-mediated loop extrusion,
we will assay genome folding, DNA methylation, and H3K9me3 with cutting edge single-cell genomics and
imaging technologies. Together, these studies will shed light on the mechanisms governing the establishment
and maintenance of H3K9me3 domains and the inter-chromosomal interactions among them in FXS.

Public health relevance
Public Health Relevance/Narrative Fragile X syndrome (FXS) is the most common inherited cause of autism spectrum disorder, and patients suffer from complex behavioral and intellectual deficits. The disease is thought to be driven by local DNA methylation of FMR1, yet we recently found Megabase-scale domains of heterochromatin encompassing long synaptic genes in FXS patient-derived cells and brain tissue. Here, using cutting-edge single-cell genomics, imaging, computational analyses, and genome engineering, we propose to dissect the cause-and-effect relationship between 3D genome misfolding, inter-chromosomal interactions, Megabase-scale heterochromatin domains, and transcriptional silencing in human models of FXS.